Intermembrane transport of lipids and metabolites by mycobacterial MmpL protein complexes

PROJECT DESCRIPTION
Infections caused by Mycobacterium spp. are very challenging to treat and multidrug-resistant strains rapidly
spread in human populations. Intrinsic and acquired multidrug resistance of these pathogens demand new
fundamental insights into underlying molecular mechanisms that will facilitate the discovery of new therapeutics.
This project is focused on understanding the mechanisms of lipid/metabolite and drug transport in
Mycobacterium tuberculosis and related mycobacteria. MmpL protein complexes are major contributors to these
processes and are important targets in current drug discovery efforts. The long-term goal of this project is to
characterize the mechanism and functions of mycobacterial MmpL transporters alone and in the context of their
protein complexes. The major objective of this application is to establish the molecular mechanisms and
structures of MmpL3, MmpL5 and MmpL7 transporters and their complexes with interacting partner proteins.
These three transporters have distinct substrate specificities, functions, and mechanisms, but also share certain
common traits. We will use the similarities and differences between these transporters to gain mechanistic
insights into their physiological functions. The specific aims of this application are: 1) Define the transport
activities of MmpL transporters. 2) Reconstitute and characterize the activities of MmpL transporters in
complexes with protein partners. 3) Define structures of MmpL transporters alone and in complexes with
interacting partners. These studies will be performed by a multi-disciplinary team of investigators: Edward Yu
(Structural Biology), Mary Jackson (Microbiology and Mycobacterial Physiology), Benjamin Swarts (Synthetic
Chemistry) and Helen Zgurskaya (Biochemistry and Membrane Transport). The major outcome of the proposed
studies will be novel structural and mechanistic insights into MmpL transporters and their roles in the assembly
of the mycobacterial outer membrane and antibiotic resistance. If successful, the proposed studies will facilitate
the development of new anti-mycobacterial agents.

Public health relevance
PROJECT NARRATIVE This proposal is focused on uncovering fundamental insights into mechanisms of lipid and drug transport in Mycobacterium tuberculosis and related pathogens. Human infections caused by these pathogens are notoriously difficult to treat with antibiotics due to particularities of their physiology, pathogenicity, and antibiotic resistance mechanisms. Successful completion of this project will be transformative to the field of mycobacterial physiology and biochemistry and will provide effective tools for use in antimycobacterial discovery.